Determining the Role of p97 Adaptor UBXD8 in Peroxisome Function

PROJECT SUMMARY/ ABSTRACT
Peroxisomes are ubiquitous organelles that are integrated into essential metabolic functions of eukaryotic
cells such as purine catabolism, bile acid and ether phospholipid synthesis, as well as β- and α- oxidation of very
long chain fatty acids (VLCFA). Deficiencies in peroxisomes have been associated with a variety of disease
states, including inherited neuropathologies, aging, heart disease, cancer, and diabetes. Their importance is
further underscored by the occurrence of peroxisome biogenesis disorders (PBD); serious early childhood
pathologies that are often fatal and characterized by altered lipid metabolism. Peroxisomes abundance can be
modulated by cellular metabolic demand via de novo synthesis at the Endoplasmic Reticulum (ER). Conversely,
when they are no longer needed, peroxisomes are degraded via a selective form of autophagy known as
pexophagy. Recent studies have found that peroxisomes and lipid droplets (LDs, lipid rich organelles that
regulate the storage and hydrolysis of neutral lipids such as TAG and sterol esters), arise from the same ER
sub-domains. The Ubiquitin-X domain 8 (UBXD8) is an ER-embedded adaptor to the p97 AAA-ATPase. At the
ER UBXD8 has essential functions in ER-associated degradation (ERAD) as well as fatty acid and sterol
homeostasis. Work from several groups, including our own unpublished studies indicate that UBXD8 regulates
the abundance of LDs.
In quantitative proteomic studies comparing the proteomes of wildtype and UBXD8 null cells, we find that
loss of UBXD8 decreases the abundance of numerous peroxisomal proteins. Furthermore, from lipidomics
analysis we identified an increase in VLCFAs and a decrease in cholesterol in UBXD8 knockout (KO) compared
to wildtype (WT) cells. Interestingly, it is observed PBD patients accumulate VLCFAs and have consistently
reduced cholesterol plasma levels. I have identified a significant decrease in peroxisome number and an
increase in peroxisome size in UBXD8 KO cells relative to wildtype cells. We were further able to rescue this
aberrant peroxisome phenotype by complementing UBXD8 KO cells with wildtype UBXD8. Additionally,
consistent with our proteomics analyses, we found that loss of UBXD8 in different cells results in significantly
lower levels of several peroxisomal proteins. Although the mechanism by which UBXD8 regulates ERAD is well
understood, its role in peroxisome function is completely unknown. The proposed work will test the
hypothesis that UBXD8 plays a critical role in peroxisome biogenesis at the ER. Proposed experiments
will use advanced microscopy and proteomics techniques to ascertain the role of UBXD8 in peroxisome
homeostasis and examine the effects of UBXD8 KO in a metabolically relevant cell line. A molecular
understanding of the mechanisms and signaling pathways controlling peroxisome abundance may allow for
modulation of peroxisome function during disease states.

Public health relevance
PROJECT NARRATIVE Deficiencies in peroxisomes have been associated with a variety of disease states, including inherited neuropathologies, aging, heart disease, cancer, and diabetes. Experiments outlined in this proposal seek to elucidate the importance of UBXD8 in maintaining peroxisome homeostasis and the subsequent impact on cellular pathways involved in the development of lipid metabolic diseases. Results from this proposal will inform novel molecular mechanisms by which peroxisome abundance is regulated thus bringing us closer to potential therapeutic targets for treating lipid metabolic diseases.